Actions to Decrease Disparities in Risk and Engage in Shared Support for Blood Pressure Control (ADDRESS-BP) in Blacks

Project Summary Abstract This diversity supplement will provide Ms. Deborah Onakomaiya with invaluable mentorship, training, and advanced research experience via the recently funded Actions to Decrease Disparities in Risk and Engage in Shared Support for BP Control (ADDRESS-BP) grant (#HL151310). The research portion of this supplement aims to conduct an environmental scan of primary care facilities (PCFs) utilizing a mixed-mixed methods approach to evaluate barriers, facilitators, and readiness of these practices to participate in the parent study’s (ADDRESS-BP) intervention across 20 New York City-based PCFs. The first step needed to successfully implement an evidence-based intervention (EBI) is examining the context of the implementation site i.e. understanding factors that might hinder or facilitate the implementation of the EBIs within the context of a clinic, primary care facilities, or community organization, in which the EBI will be implemented. One way to achieve this is by using an environmental scan. An environmental scan is a structured practice capacity assessment that combines qualitative (observations, key informant interviews) and quantitative (surveys) data collection methodologies to develop a robust understanding of the internal conditions and external factors that affect an organization. The proposed diversity supplement will utilize an environmental scan toolkit guided by the Consolidated Framework for Implementation Research (CFIR) to assess and document factors related to the inner and outer setting domains of CFIR that might influence PCFs capacity to implement evidence-based interventions for hypertension control among Black patients. Findings from the environmental scan will be useful for understanding the implementation setting’s readiness to receive the intervention, providing key areas of modification for the intervention before it is delivered at PCFs, building key relationships with medical staff and workers at PCFs, and finally developing a shared understanding of project roles and responsibilities, before intervention delivery. In this diversity supplement, Ms. Onakomaiya aims to: 1) evaluate through an environmental scan the practice factors and characteristics, which may influence the feasibility and acceptability of implementing ADDRESS-BP in the PCFs. 2) assess culture, attitudes, and beliefs among PCF staff regarding the Implementation of ADDRESS-BP. The combinations of findings from both aims will determine the best approach for adapting and tailoring the intervention and the practice facilitation Implementation strategy at participating PCFs before the UH3 Implementation Phase of the parent study.

Public health relevance
PROJECT NARRATIVE This diversity supplement will provide Ms. Deborah Onakomaiya indispensable mentorship, training, and advanced research experience via the recently funded Actions to Decrease Disparities in Risk and Engage in Shared Support for BP Control (ADDRESS-BP) grant (#HL151310).The research portion of this supplement aims to conduct an environmental scan of primary care facilities (PCFs) utilizing a mixed-mixed methods approach guided by the Consolidated Framework for Implementation Research (CFIR) to evaluate barriers, facilitators, and readiness of these practices to participate in the parent study’s (ADDRESS-BP) intervention across 20 New York City-based PCFs. The findings from the study will determine the best approach for adapting the main intervention and the practice facilitation Implementation strategy at PCFs before the UH3 implementation phase of the parent study and will allow Ms. Onakomaiya to further hone her skills in order to prepare her to apply for more advanced career research training awards, before the completion of her doctoral degree.